The role of mitochondrial redox stress in the impaired Nrf2 response to contraction in aged muscle

Abstract
Aging is associated with impaired stress resilience defined as a loss of the ability of cells, organs, and organisms
to adapt to physiological or pathological stressors. Evidence suggests that this loss of resilience arises before
any overt pathology, and eventually contributes to the loss of function, disease, and death. However, the cellular
mechanisms that drive this process are poorly understood. In order for cells to adapt to environmental and
endogenous stressors they need to be able to communicate the stress signal through signal transduction
mechanisms. However, in order for transient stress signals to be effective, they should be low under resting
conditions. The Nrf2 antioxidant response element activates early changes in gene expression to enhance redox
protective mechanisms in response to acute redox stress associated with muscle contraction. In healthy
individuals this leads to an adaptive response to restore redox balance and increased cellular resilience to future
stresses. We have found that Nrf2 is chronically activated under basal conditions and has an attenuated
response to muscle contraction in human aged skeletal muscle. In addition, we have found that aging is
associated with elevated reversible oxidation of the thiol proteome, a primary signal transduction mechanism
driving redox adaptation, and that reducing mitochondrial redox stress restores the thiol proteome to that found
in young adults. Here we hypothesize that mitochondrial redox stress in aging muscle is the chronic low-level
stress that impairs the signal transduction communication in the cell underlying the impaired Nrf2 response to
muscle contraction. Aim 1 tests whether decreasing mitochondrial redox stress in aged or increasing
mitochondrial redox stress in young improves or impairs the Nrf2 activation to acute muscle contraction. Aim 2
tests whether the manipulation of mitochondrial redox stress and basal Nrf2 activation improves the adaptive
responses to exercise training in aged mice. This research uses skeletal muscle contraction as a model to
generate new insights into the molecular mechanisms underlying reduced resilience with age. A more complete
mechanistic understanding of this phenomenon will provide therapeutic targets for aging and disease by
identifying stressors that are necessary and sufficient to drive the aging process.

Public health relevance
Project Narrative Aging organisms show impaired redox homeostasis and a blunted ability to respond to redox stressors. This is associated with declining stress resilience and increased risk for age-associated diseases. We propose to manipulate the chronic mitochondrial redox stress in models of acute and chronic exercise in young and aged mice to test whether mitochondrial dysfunction underlies the decreased adaptive response with age that drives the decline in muscle function and healthspan.